Basolateral brain endothelial cilia and its role in promoting vascular stability

PROJECT SUMMARY
Endothelial cilia are normally considered to be present on the apical side of the vessel wall. Our data shows
that endothelial cilia are also found on the basolateral side of the vasculature. The significance of this cilia
location is not known. We hypothesize that endothelial cilia on the basolateral side is critical for cell-cell
communication with cells of the neurovascular unit such as pericytes to promote vascular stability. In this
proposal, we propose that vascular stability is governed by interaction between endothelial cell (EC)-cilia and
pericytes through an interaction with basement membrane that interfaces between them. Molecules at the
interface namely heparan sulfate proteoglycans (HSPGs) and the modifications associated with them are
responsible for binding ligands secreted by ECs such as platelet derived growth factor-BB (PDGF-BB) to
promote interaction with pdgfr-β+ pericytes. Signals emerging from ciliogenesis such as ARL13b and vascular
stability promoting molecules such as PAK2 are responsible for PDGF-BB secretion and promote metabolic
homeostasis in ECs. We investigate the hypothesis PDGF-BB induced PAK2-ARL13B autocrine EC signal
promotes PDGF-BB secretion in brain ECs, facilitates metabolic homeostasis to influence endothelial HS
sulfation, ensuring basolateral retention of PDGF-BB to facilitate recruitment of pericytes and promote vascular
stability. We will investigate this hypothesis in three aims. In aim 1, we evaluate the PDGF-BB localization in
vivo in the context of matrix and basolateral EC-cilia. In aim 2, we investigate basolateral EC-cilia role in
pericyte recruitment. In aim 3, we determine whether the EC-cilia:HS interface promotes brain vascular
stability. We use a combination of zebrafish, mice and primary human brain microvascular ECs model along
with approaches of genetic mutant, loss- and gain-of function strategies, and microfluidic based co-culture
systems to investigate these questions. The significance of this proposal is that understanding the basolateral
EC-cilia communication with pericytes, and the underlying mechanisms associated with it, will offer avenues for
intervention in conditions where vascular stability is compromised. The innovation is conceptual in nature, and
merges three fields of EC-cilia, PDGF-BB and HSPG biology to address the vascular stability question. The
impact of this work is the potential use of PDGF-BB as a repurposing candidate molecule for brain vascular
stability.

Public health relevance
PROJECT NARRATIVE Vascular stability is mediated by interaction between brain endothelial cells and pericytes. In this application, we are investigating the function of the basolateral location of a microtubule-based organelle called cilia in brain endothelial cells in facilitating the underlying heparan sulfate-mediated ligand retention mechanisms to promote pericyte cell recruitment and vascular stability. Identifying these mechanisms will facilitate targeting endothelial cilia to promote vascular stability, and advance the mission of NIH to develop novel strategies that promote health of patients afflicted with intracranial hemorrhages.